meQTL Discovery in Admixed Human Genomes Facilitates Estimates of Epistasis

Personalized genetics is poised to revolutionize healthcare; however, despite advances, genetic
prediction and portability of critical variants remains too limited for clinical use. Genetic
prediction is error-prone when applied to individuals with genetic ancestries different from
discovery cohorts, often predicting disease risk little better than random in non-European
samples. We propose understanding an underlying cause of this loss of prediction accuracy by
assessing the extent of GxG interaction effects across ancestries. Using an innovative
approach, we tackle this statistically challenging problem by 1) modeling effect sizes of meQTLs
on different ancestry haplotypes in an admixed African sample from the same population --
thereby controlling for GxE, and 2) using highly heritable genome-wide methylation phenotypes,
affording us thousands of observations per participant rather than a single phenotype (e.g.
presence of cardiovascular disease). Our study design allows us to assess whether the
presence of ancestry-dependent interactions is a common factor in the variability of SNP effect
sizes across populations. Outcomes of this grant include: generating a large genome-wide
methylation dataset from 500 admixed South Africans, paired with underlying genome-wide
DNA variation. We will further estimate the fraction of meQTLs with ancestry-specific effects and
thereby comprehensively provide a snapshot of the frequency of GxG interactions in the human
genome. These results will motivate investigation of GxG effects in a broader set of biomedical
phenotypes and the extent to which they contribute to poor portability of polygenic risk across
populations.

Public health relevance
Project Narrative The clinical benefits of precision medicine have been limited because genetic predictions in people with ancestries different from the overwhelmingly European- ancestry discovery cohorts are highly error prone. Among the possible factors that can cause this portability issue, gene-by-gene interaction or “epistasis”, has received much less attention as compared to differences in linkage disequilibrium or population-specific causal variants. This study will estimate the extent that gene-by-gene interactions impact phenotypic variation by testing for ancestry-specific effects on methylation in an admixed African population.